PHYSIOLOGIC EFFECTS OF IGF 1 IN ANOREXIA NERVOSA AND NORMAL VOLUNTEERS

The goal of this protocol is to investigate the acute effects of IGF-I on bone metabolism in patients with Anorexia Nervosa to fed and fasted normal subjects.